Novel approaches to study AMPA receptor trafficking and LTP

Project Summary
The overall goal of this proposal is to elucidate the molecular mechanisms of AMPA receptor (AMPAR)
trafficking in the context of excitatory synaptic transmission and plasticity. This five-year career development
program is designed to prepare the candidate of this K99/R00 Pathway to Independence Award, Dr. Javier
Diaz Alonso, for an independent scientific career. It will build on Dr. Diaz’s background in synaptic transmission
and plasticity, while expanding his toolbox in electrophysiology, molecular biology and biochemistry.
Dr. Diaz is a postdoctoral fellow with Dr. Roger Nicoll at UCSF. The training program will take place under the
guidance of Dr. Nicoll, who has outstanding mentoring experience. He will oversee Dr. Diaz’s scientific
progress, while preparing him for the transition to an independent career.
Long-term potentiation (LTP), where repetitive stimulation of afferents results in the accumulation of AMPAR in
the postsynapse, is by far the most studied form of synaptic plasticity, and is considered the most compelling
model explaining the cellular and molecular basis of learning and memory formation. Considerable progress in
the understanding of this process has been achieved, but fundamental issues remain to be elucidated.
This proposal will explore 3 fundamental questions about AMPAR trafficking in the context of LTP: 1) What is
the relative contribution of AMPAR exocytosis vs lateral diffusion in LTP? Together with his mentor and
advisor Dr. Michael Tadross, Dr. Diaz has designed a novel tool that will enable the disambiguation of the
contribution of exocytosed AMPAR during LTP. 2) What is the role of the extracellular amino-terminal
domain (ATD) of AMPAR subunits and its interactions with synaptic cleft proteins? In this proposal, Dr.
Diaz will dissect the roles of the extracellular domains of various AMPAR subunits, and identify the synaptic
cleft proteins that interact with them, following a series of proteomic approaches that have been delineated in
close collaboration with advisors Dr. Katherine Roche and Dr. Alma Burlingame. 3) What is the role of the
cytoplasmic carboxy-terminal domain (CTD) in AMPAR trafficking during LTP? Dr. Diaz will undertake
several experimental approaches to rigorously determine whether recent results supporting a “CTD-centric”
model of AMPAR trafficking during LTP and previous observations supporting a major role for the ATD are
reconcilable. This is an essential requirement for the LTP field to move forward.
Dr. Diaz’s long-term career goal is to lead an independent research laboratory in basic neuroscience as a
tenured-track principal investigator in an academic research institution. He will apply a multidisciplinary
approach combining biochemistry, cellular and molecular biology, imaging and electrophysiology, together with
genetic manipulations to establish a unique research line aimed at understanding the mechanisms that govern
synaptic transmission, underlie synaptic plasticity and give rise to neurological disease.

Public health relevance
Project narrative Despite decades of research, fundamental questions persist about the molecular underpinnings of long-term potentiation (LTP), regarding the origin of the AMPA receptors (AMPARs) that accumulate in the postsynapse, as well as the specific molecular determinants within the AMPARs involved. Here I propose the use of novel pharmacological, molecular and genetic tools to disambiguate some of the most technically challenging and controversial aspects of LTP. The innovative, multidisciplinary and rigorous approach proposed herein promises the elucidation of critical molecular aspects of learning and memory formation, and will substantially move forward the LTP field.